Data management and analysis

ABSTRACT
Vaccines capitalize on our knowledge of the immune system to safeguard against infectious diseases and
historically have revolutionized human health. However, the powerful success of vaccination strategies is not
complete and certain vulnerable populations, even when receiving the recommended regimen, have ineffective
or inefficient responses. A fundamental challenge in clinical medicine and public health is to understand the
mechanisms underlying the heterogeneity of responses in these populations in order to design rational
approaches to improve vaccine strategies. Addressing this challenge will require integration of information about
the complex interactions among cells and molecules of the immune system across time and space. The projects
in this proposal will carry out systems-level immune profiling of vaccination responses across three cohorts of
vulnerable patient populations: autoimmune patients with B cell depletion (Project 1), aged and frail individuals
(Project 2), and patients with sickle cell disease (Project 3). A multi-omics immune profiling core will generate
multi-omics data from longitudinal samples of circulating immune cells along with tissue biopsies to capture the
early response in situ in the skin and peak responses in draining lymph nodes. This Data Management and
Analysis Core (DMAC), led by Dr. Steven Kleinstein, will support the database, bioinformatics analysis and
complex data analysis needs of Projects 1, 2 and 3. In addition, the core will collaborate with project investigators
on experimental design and reporting, and provide a training environment for project personnel on software tools
and principles of methods and interpretation of results. Specifically, the DMAC will:
(1) Provide a secure data management system for clinical and research data.
(2) Submit data to the NIAID ImmPort repository and other public portals designated by NIAID, to ensure
that all data are findable, accessible, interoperable, and reusable (FAIR).
(3) Provide comprehensive biostatistical analysis support and consultation.
(4) Analyze and integrate cohort-wide data using multivariate statistical approaches to discover immune
signatures associated with vulnerable populations and differential vaccine responses.
(5) Support investigators in Projects 1-3 by carrying out analyses to address their scientific questions.
(6) Collaborate with Core C (Multi-omic Immune Profiling) on pre-processing of all immune profiling data,
submission of raw and computable data into the management system, and systems-level analyses.
(7) Integrate data across projects to detect common and unique signatures of vaccine responses.
(8) Actively participate in the HIPC Data Management and Integration subcommittee.
(9) Continue our efforts within HIPC towards the development and adoption of common data standards.